Precision Delivery and Imaging to Enhance Solid Tumor Therapy

OVERALL PROJECT SUMMARY
Precision delivery, imaging and therapy of solid tumors (P01)
Precision medicine is an approach for disease diagnosis, treatment and prevention that considers individual
patient variability in genes, environment, and lifestyle. The aspiration is to use molecular targeted therapies
according to `omic' categorization of targeted expression, drug sensitivity and resistance and select a targeted
therapy most appropriate for each patient. Most drugs available to implement precision medicine, including
chemotherapies and antibodies, require high near-toxic doses only to have small amounts enter solid tumors in
patients, and frequently only modest or temporary effects. Delivery may indeed be a universal problem for both
tumor imaging and therapy. Delivering drugs precisely into tumors is necessary to maximize therapeutic potency,
but is not currently possible.
In this era of precision oncology, tremendous progress has been made in the treatment of hematological
malignancies; however, for eradicating solid tumors, promising and even existing therapies could be improved
significantly with better delivery systems that actively bypass vascular barriers. While targeting strategies have
evolved, the long-standing challenge remains of delivering drugs and imaging agents across vascular barriers.
Our overall goal is to boost precision drug delivery into solid tumors and lesions by exploiting a highly precise
active transvascular transport pathway mediated by the caveolae pumping system. We have identified a tumor-
induced target concentrated in specifically in tumor caveolae, and successfully developed the first antibody to
penetrate solid tumors actively, rapidly and specifically in preclinical models and deliver attached cargo.
We propose here to translate our novel caveolae-targeting strategy into new and enhanced treatments and
diagnostic tools for use in human clinical trials. Project 1 will focus on the development of precision antibody
imaging agents and radiotherapy of solid tumors for testing in preclinical models. Project 2 will develop novel
drug immunoconjugates for clinical testing. Project 3 will evaluate novel caveolae-targeted imaging and
therapeutic agents by conducting toxicology studies, a pilot imaging study in human patients to study
biodistribution of radiolabeled CTA, and a phase 1 dose escalation study of cisplatin-based CTA conjugates in
patients with solid tumors. If successful, this program project will have developed the first precision imaging and
therapeutic agents that could radically alter how we treat cancer and metastatic disease.

Public health relevance
OVERALL PROJECT NARRATIVE Existing drug therapies for cancer rely on passive delivery into solid tumors and have limited ability to penetrate tumors, which can greatly curtail therapeutic activity. Our strategy is to boost delivery by >100-fold by exploiting an active transport pathway we discovered that concentrates antibodies and drugs precisely inside solid breast tumors and exhibits greatly improved therapeutic efficacy in preclinical models. This program intends to translate our new delivery system into the clinic to generate and test the first precision imaging and therapeutic agent, and if successful, could yield a paradigm shift in how drugs and diagnostic agents are delivered to treat cancer and metastatic disease.